The Effects of Structural Inequities and Syndemics on Willingness to Participate in HIV Research among Black Women

PROJECT SUMMARY
Black women (BW) in the US are disproportionately affected by HIV. Concurrently, Black women face
sociostructural inequities including structural racism, HIV stigma, and medical mistrust, in addition to the
syndemic effects of substance use, and intimate partner violence, and adverse mental health. These factors act
as barriers to health seeking behaviors that contribute to poor HIV outcomes. BW’s participation in HIV clinical
research remains historically low and BW’s participation in HIV research (i.e., prevention, treatment, cure), which
remains historically low, is contextualized within a system that does not consider their intersectional identities
(i.e., race, gender), while routinely excluding women due to biological (e.g., reproductive potential, menstruation,
pregnancy), social (e.g., restrictive contraception requirements, provider bias, perceived as “hard to reach”), and
structural factors (e.g., lack of welcoming research spaces including extended hours and childcare support).
While studies have identified factors that limit women’s participation in HIV research, there is limited data on
perceptions of HIV research participation among BW. The prevalence of illicit substance use (e.g., cocaine,
amphetamines) among Black women is higher than the national average. Consequently, there is a significant risk
of BW not benefitting from HIV related scientific advances (i.e., access to HIV medications, curative therapies)
derived from research. Guided by syndemic theory and intersectionality framework, this explanatory sequential
mixed methods study will utilize a case control approach to elucidate the effects of sociostructural inequities and
past-year substance use, and past-year intimate partner violence, and adverse mental health on participation in
HIV research among BW (Aim 1). For the case-control portion of the study, we will recruit, screen, and match
participants 1:1 across case and control groups (n=280, cases (n=140): participated in research; controls (n=140):
not yet participated in HIV research) along factors of (a) HIV serostatus and (b) recruitment source
(sociobehavioral, clinical, vaccine, biomedical prevention study and non-research efforts. Understanding these
effects on BW participation in HIV research may elucidate aspects for intervention (e.g., policy changes regarding
stopping rules, minimum participant thresholds) to ensure more diverse study populations in HIV research. The
proposed study will include three groups: a) BW enrolled in ongoing sociobehavioral research studies by
members of the mentoring team, LinkPositively (R34MH122014; PI: Stockman) and Women Shine;
(R01MH125785 PI Stockman) who agreed to be contacted about future research opportunities (n=40), b) BW
with histories of research participation who agreed to be contacted about future research opportunities, and those
seeking care at AIDS Clinical Trials Group clinical research sites without a history of research participation (n=65),
c) participated in LinkPositively (Grant #R34MH122014; PI: Stockman; n=70), an mHealth HIV intervention for
BWH in California and Oklahoma affected by interpersonal violence, c) Participants of the Enhanced Peer
Involvement in Care Amplifying the Voices of BW (EPIC) program embedded within existing peer navigation
programs in community-based organizations located in Ending the HIV Epidemic jurisdictions in the Southern
United States, and d) BW without HIV and with histories of research participation who agreed to be contacted
about future research opportunities and those seeking care at an HIV Vaccine Trials Network clinical research
site without a history of research participation (n=140). Next, we will qualitatively explore perceptions of and
facilitators and barriers to participation in HIV research among BW with and without HIV (Aim 2).The proposed
study, which is in response to PAR-22-172, will support the scientific investigation by underrepresented pre-
doctoral students, and is the first to attempt to quantify and contextualize the impacts of sociostructural inequities
and syndemics on BW’s willingness to participate in HIV research to inform multilevel efforts and interventions to
conduct equitable and diverse research.

Public health relevance
PROJECT NARRATIVE Black women with BW face sociostructural inequities including structural racism, HIV stigma, and medical mistrust in addition to the syndemic effects of substance use, intimate partner violence and adverse mental health, which act as barriers to health seeing behaviors that contribute to poor HIV outcomes. Additionally, BW have been historically under enrolled in HIV clinical research that does not contend with these historical circumstances. As a first-generation, Black female predoctoral student, this explanatory sequential mixed methods R36 dissertation proposal is the first to attempt to quantify and contextualize the impacts of sociostructural inequities and syndemics on BW’s participation in HIV research to inform multilevel intervention efforts to conduct equitable and diverse research.